The impact of two-pore channel calcium signaling on MR1 antigen presentation of Mycobacterium tuberculosis metabolites

PROJECT SUMMARY
Tuberculosis (TB) caused by the intracellular pathogen Mycobacterium tuberculosis (Mtb) is the leading
cause of infectious disease morbidity and mortality worldwide. Immune system sampling of the intracellular
environment for Mtb antigens is crucial to control infection and prevent active tuberculosis. Major
Histocompatibility Complex, Class I-Related molecule (MR1) is a conserved nonclassical antigen presenting
molecule expressed in several cell types that presents Mtb derived riboflavin metabolites to MR1-restricted T
cells (MR1Ts). MR1 antigen presentation to this subset of CD8+ T cells is poised to play a crucial role in
controlling Mtb infection; MR1Ts are enriched in the lung and rapidly release pro-inflammatory cytokines and
apoptotic factors to kill infected cells. Our laboratory has found that endosomal trafficking facilitates MR1 antigen
presentation, yet the exact mechanisms by which MR1 loading and trafficking to the cell surface occurs are not
known. The specific purpose of this project is to decipher molecular mechanisms of endosomal trafficking to
ultimately inform our understanding of MR1 antigen presentation. We have found that endosomal calcium
signaling mediates MR1 antigen presentation during Mtb infection. Interference of two-pore calcium channels
(TPCs) via siRNA-mediated knockdown specifically decreases MR1 presentation of Mtb antigens. Nicotinic acid
adenine dinucleotide phosphate (NAADP) facilitates endosomal calcium release by activating TPCs; treatment
with a selective, membrane-permeant NAADP antagonist or knockdown of an NAADP binding protein important
for TPC activation also decrease MR1 presentation of Mtb antigens. NAADP is synthesized from NADP, and this
reaction requires catalysis by ADP-ribosyl cyclase. Cluster of Differentiation 157 (CD157) is one of few proteins
that possesses this enzymatic activity. The central hypothesis of this proposal is that Mtb infection triggers
CD157-mediated NAADP generation to facilitate MR1 antigen presentation of the Mtb-infected cell via the TPC.
To test this hypothesis, I will infect antigen presenting cells with Mtb and assess MR1 antigen presentation using
a human MR1T cell clone. Experiments in Aim 1 will further elucidate the role of TPC calcium release in MR1
antigen presentation via T cell IFN-γ release ELISpot assays, and characterize interactions of TPCs with MR1
and Mtb via live-cell imaging. Aim 2 will identify the source of NAADP and establish where NAADP generation
occurs in relation to MR1 antigen presentation of Mtb-infected cells. This proposed work will have broad
implications for how endosomal calcium sensing facilitates recognition of Mtb-infected cells. The results from
this research will elucidate key, novel pathways that underpin the immune response to Mtb, which have potential
to inform tuberculosis vaccine development.

Public health relevance
PROJECT NARRATIVE The immune system has developed specialized mechanisms to recognize intracellular infection by pathogens such as Mycobacterium tuberculosis; the MR1 antigen presenting molecule senses Mtb-derived riboflavin metabolites and presents them to MR1-restricted T cells to generate rapid pro-inflammatory responses. The proposed research will investigate the role of endosomal calcium signaling, specifically via two-pore calcium channels, in MR1 antigen presentation. The results from this research will elucidate requirements for MR1 antigen presentation during Mtb infection, which have the potential to inform tuberculosis vaccine development.